APOMORPHINE ON SERUM GROWTH HORMONE IN PSYCHIATRIC PTS AND NORMAL VOLUNTEERS

The dopamine agonist, apomorphine, stimulates the secretion of growth hormone in normal volunteers. Apomorphine stimulates the secretion of GH via D2-dopamine receptor-mediated mechanisms. Apomorphine provides a pattern for GH secretion. Comparisons between psychiatric patients and normal volunteers will help establish specific abnormalities of the dopamine system.